Patient Perspectives on Health Insurance

This protocol was intended to (1) design a research tool (simulation model) to facilitate group decision making and (2) utilize this tool to examine how patients enrolled in managed care organizations would choose to define their health insurance benefit package. Thus far, the study instrument has been designed and has been pilot tested. The study design has been completed. Study subjects were recruited and 50 group exercises have been conducted. Data collection was complete on June 23, 2000. Data are being processed and analyzed.